Optimizing population health outcomes in diabetic retinopathy through personalized and scalable screening strategies

Project Summary / Abstract
According to the National Eye Institute (NEI), early detection and timely treatment can reduce the risk of severe vision loss
from diabetic retinopathy (DR) by 95%. Yet, DR remains the leading cause of blindness among American adults. By 2030,
54.9 million Americans are expected to have diabetes. The prevalence of vision-threatening diabetic retinopathy (VTDR)
among people with diabetes is 4.4% and 10.2% in the US and worldwide, respectively, representing over 28 million people
at risk of blindness. Because DR causes no pain, vision loss, or other symptoms at its early stages and only 50% of people
with diabetes receive annual eye exams, many will be unaware of their disease until vision loss is irreversible.
Retinal Care Inc. (RCI) believes that the root cause of this public health failure is more behavioral and educational than
clinical; complete adherence to screening and treatment would prevent nearly all vision loss from DR. However, 100%
adherence is not feasible, practical, or cost-effective. Eliminating blindness from DR requires a strategy shift that
acknowledges that preventing vision loss from DR does not require a 100% annual screening rate; it requires only that all
patients with VTDR are evaluated by an eye care provider and adhere to follow up recommendations.
RCI's approach to cost-effectively eliminating blindness from DR is to prioritize patients who are most likely to require
immediate attention and devote the resources necessary to ensure they are evaluated by an eye care provider. The proposed
project is designed to accomplish this goal through VTDR risk prediction; targeted patient engagement, education, and
behavioral interventions; and optimization of the full system to achieve maximum population benefit.
In Aim 1, RCI will leverage our existing Data Repository and machine learning methods to predict VTDR risk using
electronic health record (EHR) and healthcare insurance claims data, with the initial goal of correctly placing over 90% of
patients with VTDR in the highest-risk half of the population when ordered by risk. In doing so, RCI can focus patient
engagement resources on patients who are most likely to need immediate evaluation and treatment, rather than diverting
resources to patients who are less likely to require immediate attention.
In Aim 2, RCI will use mixed methods framed by the Integrated Behavior Model to identify barriers and motivators for
screening and assess their relative importance, develop and implement a survey instrument to elicit willingness to participate
in screening based on motivating factors and barrier removal, and use natural language processing to detect barriers and
facilitators for diabetic eye screening from patient communications.
In Aim 3, RCI will create an agent-based simulation tool to guide care coordination recommendations in a way that
maximizes population health outcomes subject to constraints on time and cost. The tool will identify optimal intervention
strategies and be adaptable to changes in cost, disease burden, patient preference, population characteristics, and other
parameters. Decisions that will be optimized include resource allocation as a function of risk, intervention timing, screening
modality, communication strategies, barrier removal strategies, and other modifiable aspects of the system.

Public health relevance
Project Narrative Diabetic retinopathy (DR) is expected to affect over 11 million people in the US by 2030 and is the leading cause of blindness in American adults, despite vision loss being almost entirely preventable with timely detection and treatment. To prevent blindness from DR, the Retinal Care-DR program is designed to eliminate the deficiencies of the current care delivery model by implementing a first-of-its-kind, personalized care coordination program guided by individual disease risk and population-level outcomes. This will be accomplished through the application of machine learning to prioritize patients for care coordination by disease risk, development of tools to identify and understand the impact of barriers and motivators for diabetic eye screening for high risk patients, and care coordination decision logic guided by agent-based simulation to maximize population health outcomes subject to financial constraints.